The Volunteering-in-Place Program for Apathetic Assisted Living Residents with ADRD

ABSTRACT
Apathy, defined as a reduction of self-generated voluntary and purposeful behaviors, affects
approximately two thirds of adults with Alzheimer’s disease and related dementias (ADRD). Apathy is associated
with increased disability, poorer quality of life and mortality among adults with ADRD. Apathetic adults with ADRD
are also more likely to be sedentary for long periods of time, which results in declines in function, and has a
negative impact on overall health and quality of life. The underlying mechanisms for apathy in ADRD include a
disruption in the neurocircuitry in the prefrontal cortex plus an increased vulnerability to stressors. The stressors
include patient factors (e.g. poor self-efficacy to engage, and loss of usefulness), caregiver knowledge and skills
(e.g. ability to restructure complex activity into simple components) and social and physical environmental factors
(e.g. lack of opportunities for meaningful activities, lack of rewards such as positive reinforcement). Engagement
in volunteering benefits all adults including those with ADRD. However, such activities are rarely tailored to
individual strengths and interests and are not designed to support engagement and completion for apathetic
adults with ADRD. Our prior research has repeatedly shown that assisted living (AL) residents with ADRD are
interested in volunteering, but they encounter challenges including: 1) lack of access to appropriate volunteer
opportunities, 2) cognitive challenges that make it difficult to complete volunteer tasks without support, and 3)
low self-efficacy to volunteer. We developed the Volunteering-in Place (VIP) Program to overcome the
challenges to volunteering and create personalized volunteer activities available to AL residents with mild to
moderate ADRD based on their abilities and interests. The VIP Program was conceptualized using the Social
Ecological Model to address the stressors that contribute to apathy, and addresses intrapersonal (e.g., age,
gender, cognition), interpersonal (e.g., self-efficacy based interactions between the resident and caregivers),
institutional (policies and environments within the setting), and community factors (e.g., volunteer opportunities
that can be done in the AL setting that benefit the community), that influence volunteering among AL residents.
Social Cognitive Theory guides the interpersonal motivational approach to strengthen self-efficacy and outcome
expectations. The purpose of this proposed pilot study is to test the preliminary efficacy of the VIP Program to
improve apathy and decrease sedentary behavior. Additionally, we will test that the mechanisms underlying
apathy are due to feelings of usefulness and self-efficacy to engage in volunteer activities. We will test the VIP
Program in a cluster randomized controlled trial [VIP Program vs. time equivalent recreational activities (RA)]
with 110 residents from 4 assisted living communities. The long-term goal of this research is to decrease apathy
by increasing self-efficacy for volunteering and feelings of usefulness and decrease time spent in sedentary
activity among apathetic older adults in AL living with ADRD.

Public health relevance
PROJECT NARRATIVE Apathy, defined as a reduction of self-generated voluntary and purposeful behaviors, affects approximately two thirds of adults with Alzheimer’s disease and related dementias (ADRD). This study will test the efficacy of the Volunteering-in-Place (VIP) Program, a novel intervention to engage apathetic assisted living (AL) residents in meaningful volunteer activities by matching resident cognitive and functional abilities and preferences with an appropriate volunteer activity that can take place within the AL setting. The long-term goal of this research is to decrease apathy by increasing self-efficacy for volunteering and feelings of usefulness and decrease time spent in sedentary activity among apathetic older adults in AL living with ADRD.